Perceived Norms About Alcohol Use and HIV/STI Prevention among Adolescents and Young Adults in Rural Uganda

Adolescents & young adults (AYA) accounted for >400,000 new HIV infections in 2021 worldwide. Heavy alcohol use is a prevalent and strong modifiable risk factor for HIV transmission risk behavior. Studies from in high-income countries show that AYA often misperceive peer norms around health and health risk behavior and that these misperceptions increase risk behavior and impede health behavior. While these perceptions are modifiable risk factors, few studies of AYA in high HIV-burden settings describe how misperceptions of peer norms drive alcohol use and HIV/STI transmission risk and prevention behavior and associated health outcomes nor address how to change misperceived norms. The central hypotheses of this application are that AYA frequently misperceive peer norms about alcohol consumption and HIV/STI prevention; that these misperceptions affect their own propensities to engage in HIV/STI transmission risk behavior; and that perceived norms are malleable when AYA receive information about actual peer norms that conflicts with personal perceptions and behavior. These hypotheses have been formulated based on preliminary data showing that AYA in high-burden settings misperceive norms about alcohol use and HIV/STI transmission risk behavior, a finding that is consistent with other preliminary data demonstrating similar phenomena among adults. The preliminary data are also consistent with published trials from the US showing that AYA misperceptions can be altered through “personalized normative feedback” and other norms correction interventions wherein they are provided with correct information about actual norms. The team has engaged local leaders & educators in a high-burden setting to propose a population-based cohort study, in which they will embed a randomized controlled trial, of AYA in 3 secondary schools to achieve three specific aims: 1) Use qualitative methods to explore perceived norms around alcohol, HIV/STI transmission risk behavior, and HIV/STI prevention among AYA; 2) Estimate the causal effects of perceived norms around alcohol use and HIV/STI transmission risk behavior on HIV/STI prevention among AYA; and, 3) Conduct a mixed-methods, randomized controlled trial to test the preliminary efficacy and mediating mechanism of a personalized normative feedback intervention on behavioral intentions, heavy alcohol use, and HIV/STI prevention among AYA. The key innovation is that this study will be the first to rigorously estimate the causal influence of perceived peer norms around alcohol and HIV/STI transmission risk behavior on HIV/STI prevention among AYA in high-burden settings. The study will have significant public health impact by laying the foundation for strategies to focus on changing misperceived norms to influence HIV/STI prevention uptake among AYA.

Public health relevance
The proposed research is relevant to public health by developing novel intervention strategies to reduce heavy alcohol use and increase HIV/STI prevention behaviors among adolescents and young adults in high-burden settings. The proposed research is relevant to NIAAA Research Priorities to develop “effective prevention and treatment strategies that address the risks for the physical, behavioral, and social consequences that result from excessive drinking,” preventing “children and adolescents from beginning and continuing to drink alcohol” and “offering effective intervention for problem alcohol use at all ages.” The proposed research is also relevant to NIAAA HIV/AIDS Research Priorities to “improve HIV testing and entry to treatment for people who drink across a range of severity, including multi-level interventions and measures that impact at the population level”.